Histopathology Core

The NEI Histopathology Core processes human from donor and animal tissue, mainly ocular tissue, collected by NEI researchers to research human eye disease. The Histopathology Core processes these tissues for microscopy, sectioning it and staining slides for bright field, fluorescence and/or transmission electron microscopy.

During FY2022 the Histopathology Core received and processed approximately:

Microscopy samples: 83 samples Methacrylate, 689 Paraffin, 136 cryosections and Flat mount prep. for a total of 937 specimens.

All the slides were imaged in Zeiss Axio Scan and save in H.C. Cloud.

The following papers, as well as those listed in the bibliography, were published using the services of the Histopathology Core:

"Epithelial phenotype restoring drugs suppress macular degeneration phenotype in an iPSC and a rat model" (our reference 147999-JCI-RG-1) has been submitted to the Journal of Clinical Investigation. Ruchi Sharma (NIH), Aman George (National Institutes of Health) Malika Nimmagadda (National Institutes of Health) Davide Ortolan (National Institutes of Health) Karla Barbosa (NEI) Zoya Qureshi (National Institutes of Health) Devika Bose (National Institutes of Health) Roba Dejene (National Institute of Health)Genqing Liang (NEI) Qin Wan (NEI) Justin R. Chang (NEI)Balendu Shekhar Jha (NEI)Omar Memon (NEI) Kiyoharu Miyagishima (National Institute of Health) Aaron Rising (NEI)Madhu Lal-Nag (CDER/FDA) Eric Hanson (National Institutes of Health (NIH) Rebecca King (NIH) Mercedes Maria Campos (NEI) Marc Ferrer (NIH) Juan Amaral (NEI) David McGaughey (NEI) Kapil Bharti (NIH, NEI) 15 December 2021

Aged Nrf2-null mice develop all major kinds of age-related cataracts
Sheldon Rowan1,2,3, *, Shurong Jiang1, Sarah G. Francisco1, Laura CD Pomatto4, Zhiwei Ma5, Xiaodong Jiao5, Maria M Campos6, Sandeep Aryal7, Sheila Patel7, Binapani Mahali8, S. Amer Riazuddin9, Elia J. Duh8, Salil A. Lachke7, J. Fielding Hejtmancik5, Rafael de Cabo4, Paul G. FitzGerald10, and Allen Taylor1,2,3Invest. Ophthalmol. Vis. Sci. 2021; 62(15):10. doi: https://doi.org/10.1167/iovs.62.15.10

"Rs1h-/y exon 3-del rat model of X-linked retinoschisis with early onset and rapid
phenotype is rescued by RS1 supplementation"
Yong Zeng, Haohua Qian, Maria Mercedes Campos, Yichao Li, Camasamudram
Vijayasarathy1, and Paul Sieving Paper #GT-2021-00143RR Gene Therapy (2021)

"Cell Autonomous Lipid Handling Defects in Stargardt iPS Cell-Derived Retinal Pigment Epithelium Cells
Mitra Farnoodian1, Devika Bose1, Vladimir Khristov1, Praveen Joseph2, Indumathi Mariappan2,
Mones Abu-Asab3, Maria Campos3, Rafael Villasmil4, Qin Wan1, Arvydas Maminishkis1, David McGaughey5,
Francesca Barone1, Kenneth Boheler 6, Aparna Lakkaraju7, Ruchi Sharma1,
Kapil Bharti1* In revision

"Boobalan E, Thompson AH, Alur RP, McGaughey D, Dong L, Shih G, Vieta-Ferrer ER, Onojafe IF, Kalaskar
VK, Arno G, Lotery AJ, Guan B, Bender C, Memom O, Brinster L, Soleihavou C, Lanman L, Badea TC,
Minella A, Lopez AJ, Thomassy S, Moshiri A, Genomics England Research Consortium, Blain D, Hufnagel
RB, Cogliati T, Bharti K, Brooks BP. Zfp503/Nlz2 is required for RPE differentiation and otpic
fissure closure. Invest Ophtalmol Vis Sci. In press, August 2022.
Aged Nrf2-Null Mice Develop All Major Types of Age-Related Cataracts
Aged Nrf2-Null Mice Develop All Major Types of Age-Related Cataracts
S. Rowan, S. Jiang, S. G. Francisco, L. C. D. Pomatto, Z. Ma, X. Jiao, et al.
Invest Ophthalmol Vis Sci 2021 Vol. 62 Issue 15 Pages 10
Accession Number: 34882206 DOI: 10.1167/iovs.62.15.10
https://www.ncbi.nlm.nih.gov/pubmed/34882206

Guidelines for the use and interpretation of assays for monitoring autophagy (4th edition)
D. J. Klionsky, A. K. Abdel-Aziz, S. Abdelfatah, M. Abdellatif, A. Abdoli, S. Abel, et al.
Autophagy 2021 Vol. 17 Issue 1 Pages 1-382
Accession Number: 33634751 PMCID: PMC7996087 DOI: 10.1080/15548627.2020.1797280
https://www.ncbi.nlm.nih.gov/pubmed/33634751

Retinal Development and Pathophysiology in Kcnj13 Knockout Mice
X. Jiao, Z. Ma, J. Lei, P. Liu, X. Cai, P. K. Shahi, et al.
Front Cell Dev Biol 2022 Vol. 9 Pages 810020
Accession Number: 35096838 PMCID: PMC8790323 DOI: 10.3389/fcell.2021.810020
https://www.ncbi.nlm.nih.gov/pubmed/35096838